IND-enabling studies for eCD4-Ig as a long-acting recombinant protein therapeutic

ABSTRACT
This FastTrack SBIR grant will support pre-clinical IND-enabling studies for recombinant eCD4-Ig protein,
ahead of a first-in-human (FIH) Phase 1 clinical trial. eCD4-Ig is an antibody-like therapeutic for HIV
consisting of parts of HIV’s receptor and coreceptors fused to the constant Fc region of an antibody. Due to
being comprised of parts of HIV’s receptor and coreceptors, eCD4-Ig recognizes 100% of HIV isolates and
cannot be escaped without HIV sacrificing its ability to bind its receptor and coreceptors. The eCD4-Ig protein
we are developing has its effector function enhanced through afucosylation. Our Target Product Profile (TPP)
for eCD4-Ig is a long-acting recombinant protein therapeutic that can be dosed quarterly (i.e., every 3 months)
by subcutaneous injection as part of a long-acting combination regimen. Prior to a Phase 1 clinical trial, a
necessary milestone is the submission of an Investigational New Drug (IND) application to the FDA. Here,
we propose the preclinical IND-enabling studies that will support that Phase 1 clinical trial. In Phase I of this
SBIR grant, we will conduct the in vitro assays required for IND application submission (tissue cross-
reactivity, and immunotoxicity using human peripheral blood cells), and conduct a pre-IND meeting with the
FDA. In Phase II of this grant, we will conduct a definitive GLP toxicology study in macaques. The study will
assess changes in leukocyte and lymphocyte populations, body weight, food consumption, clinical signs,
clinical chemistries, coagulation, urinalysis, toxicokinetics, anti-drug antibodies (ADAs), and
histopathology. Safety pharmacology endpoints will include cardiotoxicity, respiratory toxicity, and central
nervous system (CNS) toxicity. Doses for the study will be set to provide a 10x safety margin. This definitive
GLP toxicology study is critical to proceed with a Phase 1 clinical trial. Completion of these studies will allow
us to submit an IND application and bring eCD4-Ig into the clinic.

Public health relevance
NARRATIVE This grant will support preclinical IND-enabling studies for an eCD4-Ig protein with enhanced ability to kill HIV-infected cells. The Investigative New Drug (IND) application is a critical step before proceeding with the first-in-human eCD4-Ig clinical trial. Completing the IND-enabling studies described here will allow this enhanced form of eCD4-Ig to enter the clinic as a long-acting injectable protein therapeutic for treating and preventing HIV infection.